Infrastructure and Opportunities Fund Management Core

CORE SUMMARY / ABSTRACT
If MGH is selected, we will manage the Infrastructure and Opportunities Fund (IOF) Core for the Nonhuman Primate
Transplantation Tolerance Cooperative Study Group (NHPCSG) program. We will take responsibility for managing
the IOF, including disbursement and tracking of IOF funds, establishing an administrative structure to manage the
IOF, and reporting on the status of IOF projects and expenditures to the NIAID and NHPCSG Steering Committee.